Epigenetic re-establishment of tumor suppression in glioblastoma

PROJECT SUMMARY
This project focuses on a new epigenetic vulnerability of human glioblastoma (GBM), the most common and
deadly adult primary brain malignancy. We discovered the bromodomain (BD)-containing chromatin regulator
BRD8 as essential to GBM lacking p53 mutations (TP53WT), which make up ~71% of cases (Sun et al., Nature
2023) (1). BRD8 maintains malignancy by crippling p53-mediated tumor suppression in a way distinct from
previously described mechanisms: it reprograms the p53 network through the EP400 histone acetyltransferase
complex and by BD-directed occupancy of the histone variant H2AZ at p53-induced targets, enforcing a
repressive chromatin state that prevents p53-mediated transactivation. Central to this application is our finding
that targeting BRD8 in TP53WT GBM remodels chromatin by evicting H2AZ and enhancing chromatin
accessibility, enabling p53 to bind and transactivate its targets. This chromatin remodeling cascade (referred to
as the “BRD8/p53 epigenetic switch” in this proposal) re-establishes p53 activity in TP53WT GBM, normalizing
gene expression, evoking cell cycle arrest, inhibiting gliomagenesis, and prolonging survival in xenograft models
of TP53WT GBM (1). We advance this work by: (i) revealing that BRD8 opposes p53 function in non-malignant
brain cells; (ii) setting up a single-cell gene expression pipeline; (iii) showing that the BRD8 BD is the only BD
that selectively reprograms the p53 network; (iv) engineering a GBM-prone mouse model with intact p53 in which
we can ablate Brd8; and (v) establishing TP53WT GBM organoids from patients. The above findings support
the hypothesis that targeting BRD8 in TP53WT GBM evokes the BRD8/p53 epigenetic switch that re-
establishes p53-mediated tumor suppression. Despite these advances, how the BRD8/p53 epigenetic switch
works, and whether it will be useful for treating patients with TP53WT GBM, remain obscure. Therefore, the goal
of Aim 1 is to define the epigenetic mechanism by which targeting BRD8 re-establishes p53-mediated tumor
suppression in TP53WT GBM organoids. This will be accomplished by: (Aim 1.1) defining the set of genes
transactivated by the BRD8/p53 epigenetic switch at single-cell resolution and characterizing the genomic and
epigenomic features of these loci; (Aim 1.2) identifying pathways induced by the BRD8/p53 epigenetic switch
that facilitate p53-mediated cell cycle arrest; and (Aim 1.3) elucidating the dynamics of the BRD8/p53 epigenetic
switch and how it is modulated by EP400. The goal of Aim 2 is to demonstrate the preclinical relevance of
targeting BRD8 to re-establish p53-mediated tumor suppression in vivo. This will be accomplished by: (Aim 2.1)
assessing the effectiveness of targeting Brd8 in engineered GBM-prone mice; (Aim 2.2) establishing the
effectiveness of targeting BRD8 in patient-derived xenograft (PdX) models of TP53WT GBM; and (Aim 2.3)
evaluating the heterogeneity of p53-induced targets in single cells of GBM from spontaneous and PdX models
and defining the cell populations impacted by the BRD8/p53 epigenetic switch.

Public health relevance
PROJECT NARRATIVE Only approximately 5 out of 100 people with glioblastoma—the most common type of cancer that starts in the brain—are alive 5 years after diagnosis; half of all patients survive just 12-14 months. We discovered the BRD8 protein as a new target that, when depleted, could prolong survival in nearly three quarters of these deadly cancer cases: those without mutations in the p53 tumor suppressor. The project’s goal is to determine how BRD8 loss revives p53 and shuts down glioblastoma, thereby paving the way for more successful therapies for people with this devastating malignancy.